NCORP: Colorado Cancer Research Program

Project Summary/Abstract
By serving as a dedicated NCORP, Western States Cancer Research (WSCR) seeks to
advance cancer research for patients, local communities, healthcare providers and hospitals in
the western mountain state region. The goal is to provide and maintain access to NCI research
and trials focused on cancer control (CC), cancer prevention (CP), cancer disparities, cancer
care delivery research (CCDR), as well as provide access to NCTN treatment and imaging
trials. Over the current funding cycle, WSCR has developed strategic partnerships with
regionally focused mid-sized healthcare systems whose organizations have a common ethos of
patient-centered high-value care and a shared commitment to implementing NCI trials in the
community setting. The consortium is diverse in its membership, not only from a regional
perspective, but also in regards to the makeup of its providers of healthcare services, ranging
from healthcare systems, to independent hospitals, to private practice physician offices. This
diversity of recruitment sites will allow for broader participation in NCORP projects, so as to
achieve WSCR’s main goal of providing patients and communities within its catchment area the
opportunity to participate in and potentially benefit from the innovative and scientifically rigorous
research projects of the NCI.

Public health relevance
Project Narrative Western States Cancer Research is a cancer clinical trial organization who seeks to provide access to NCI-sponsored clinical trials for our consortium members located in the states of Colorado, California, Washington, Kentucky, and Alaska. By partnering with healthcare systems and community hospitals, we will provide access to innovative therapies and cancer-related research projects for patients in their home communities, all the while pursuing and supporting NCI strategic research priorities. We work with healthcare systems, hospitals, providers, and patients to disseminate knowledge about clinical trial options, clinical trial participation, and clinical trial outcomes.